Administrative Core

PROJECT SUMMARY
In support of the NYU Cancer Health Disparity (CHD) SPORE, the Admin Core A will execute the administrative
needs of SPORE investigators and collaborators. Core A will optimize use of the resources and intellectual depth
available to investigators at NYU Langone Health (NYULH) to achieve the translational research goals of NIH’s
SPORE program. The Admin Core will provide strategic planning and evaluation of all SPORE activities,
establish and maintain policies for prudent financial management, and initiate communication with outside
collaborators. The Admin Core will also be responsible for regulatory compliance, resource sharing, material
transfer agreements, and the organization of travel arrangements for all SPORE meetings. A key goal is to
provide administrative support to NYU CHD SPORE research projects and cores, and the Developmental
Research Program. The Admin Core will formally evaluate the progress of each component, and revise those
not meeting expectations or failing to maintain translational focus. Another goal will be to maximize efficient use
and sharing of resources of the NYU CHD SPORE and NYU Perlmutter Cancer Center (PCC) across all SPORE
activities. Facilitation of collaborations with programs outside of NYU—including active SPORE programs and
collaborating partners—will fall under the Admin Core. As a central administration of all SPORE activities, the
Core will also organize intra-SPORE meetings and facilitate travel to the annual workshop organized by the
National Cancer Institute (NCI) as well as additional inter-SPORE and NCI/NIH network meetings that may arise.
All fiscal oversight and management for budgets and accounts of all NYU CHD SPORE activities will be managed
by the Admin Core in accordance with federal and local governments, NIH, and institutional policies. Finally, the
Admin Core will be responsible for sustaining communication and cooperation with the NYULH, PCC, and
NCI/NIH administration, and overseeing the timely submission of all required progress reports.

Public health relevance
PROJECT NARRATIVE SPORE programs are highly complex translational research enterprises that require cohesive organization and effective leadership to meet proposed scientific and programmatic aims. The Admin Core will work directly with the NYU Cancer Health Disparity (CHD) SPORE research projects and core investigators to evaluate progress, facilitate communication, and provide financial management for all activities of the SPORE. The Admin Core’s management of the SPORE will ensure the efficient use of NYULH resources, increase inter-SPORE and industry cooperation, and expand outreach to minority populations, enhancing our findings to the New York City community population and to the clinical setting.